Impact of e-cigarette characteristics and marketing on tobacco use and health: A longitudinal study among U.S. youth and adults

PROJECT SUMMARY/ABSTRACT
E-cigarette use has increased rapidly, particularly among youth and young adults. The appealing flavors are a
primary reason for young people to initiate and continue to use e-cigarettes. Young adult nonsmokers are more
likely to initiate e-cigarette use with non-tobacco and non-menthol (NTM) flavors rather than tobacco and
menthol (TM) flavors compared to current smokers, which is worrisome because e-cigarette use leads to
cigarette initiation. The types of e-cigarette may also contribute to the surge in e-cigarette use. Advanced
generation (open-system) devices deliver nicotine faster than old generation (closed-system) devices and can
rapidly reduce withdrawal symptoms. Understanding if and how e-cigarette flavors and device types affect
tobacco use behaviors is fundamental to developing regulatory activities that address the epidemic of e-
cigarette use. In addition, e-cigarettes have been marketed aggressively using strategies that are appealing to
young people. Youth exposure to e-cigarette advertising leads to e-cigarette initiation and greater
susceptibility. But the underlying mechanism has not been fully explored. A potential mechanism is that
advertising exposure reduces perceived harms and addictiveness of e-cigarettes, which in turn, lead to e-
cigarette initiation and susceptibility. Last, e-cigarette use is associated with elevated risks for cardiopulmonary
and periodontal diseases. However, evidence has been predominantly from cross-sectional data or on
relatively small samples. To fill the knowledge gap, we will use longitudinal data (Waves 1-4) from the
Population Assessment of Tobacco and Health (PATH) Study to accomplish three specific aims: (1) identify the
impact of e-cigarette flavors and types on e-cigarette use among youth (12-17 years), young adults (18-34
years), and older adults (35 years and older). We will perform multivariate logistic regression with propensity
score weights to assess the overall impact of e-cigarette flavors (NTM vs. TM) and types (open vs. closed-
system) on e-cigarette use frequency. We will perform causal mediation analysis to test the hypothesis that,
compared to TM flavors, NTM flavored e-cigarette use reduces harm and addiction perceptions of e-cigarettes,
which lead to more frequent e-cigarette use; (2) determine the impact of exposure to e-cigarette advertising on
e-cigarette initiation, use frequency, and susceptibility. Similar to Aim 1, we will perform multivariate logistic
regression to assess the effect of e-cigarette advertising exposure on the outcomes, and conduct causal
mediation analyses to assess the mediating effect of harm and addiction perceptions of e-cigarettes; and (3)
identify the effect of e-cigarette use on cardiovascular, respiratory, and periodontal health, and compare the
effects among different types of tobacco users (e.g., exclusive e-cigarette users never cigarette smokers,
exclusive e-cigarette users former cigarette smokers, dual users, and cigarette-only smokers). Findings from
our study will be directly relevant to regulatory decision-making that address e-cigarette flavors, product design
and marketing practices, and will inform future interventions that tackle the epidemic of e-cigarette use.

Public health relevance
PROJECT NARRATIVE E-cigarette use has increased rapidly particularly among youth and young adults, which may be attributed to the wide selection of flavors and device types, and aggressive marketing that targets young people. This study will use data from the Population Assessment of Tobacco and Health (PATH) Study to examine the impact of e-cigarette flavors, device types, and advertising exposure on tobacco use behaviors among U.S. youth (12-17 years), young adults (18-34 years), and older adults (35 years and above), determine the mediating role of harm and addiction perceptions of e-cigarettes in above relations, and identify the effect of e-cigarette use on cardiovascular, respiratory, and periodontal health. Findings from this study will be directly relevant to regulatory decision-making that address e-cigarette flavors, product design, and marketing practices, and will inform future interventions that tackle the epidemic of e-cigarette use.